Development of a Highly Specific and Sensitive HSV-1 and HSV-2 Diagnostic Test

Project Summary: Infections with Herpes Simplex Virus type-1 (HSV-1) or Herpes Simplex Virus type-2 (HSV-
2), the causative agents of genital herpes, are highly prevalent worldwide. The World Health Organization (WHO)
estimates that more than 3.7 billion people under the age of 50 are infected with HSV-1, and approximately 490
million are infected with HSV-2 worldwide. Despite being preventable, HSV transmission rates remain high as
most HSV carriers are unaware of their serostatus owing to the lack of a robust HSV diagnostic suitable for
routine population-based screening. Current HSV diagnostics are typically limited to active infections with high
viral loads (viral culture and swab-based assays) and have low specificity resulting in false or equivocal test
results (serology tests). Rational Vaccines is developing a novel HSV type-specific multiplex assay that will
provide improved sensitivity and specificity compared to current HSV diagnostic tests. The objective of this
Phase I proposal is to develop and complete proof-of-concept studies for a novel assay for detecting antibodies
against HSV-2 in human sera. This innovative assay will fulfill an unmet clinical need for accurate type-specific
HSV detection.

Public health relevance
Project Narrative: Herpes is one of the leading sexually transmitted infections (STIs), and it is estimated that more than half of the human population harbor a life-long latent infection with Herpes Simplex Virus type-1 (HSV- 1) or Herpes Simplex Virus type-2 (HSV-2). The proposed in vitro diagnostic (IVD) will provide a highly sensitive and specific assay for detecting HSV-1 and HSV-2 in human sera. This IVD will fill a critical need for enabling routine population-based screening for HSV infections, thereby helping curb the spread of herpes.